Systematic Alzheimer's disease drug repositioning (SMART) based on bioinformatics-guided phenotype screening and image-omics

PROJECT SUMMARY
Given the complexity of Alzheimer's Disease (AD) pathogenesis and the associated co-morbid conditions, both
the “depth” and the “width” of currently available drug repurposing solutions need to be improved in order to
deliver effective AD therapeutic solutions. The depth of a drug-repurposing project refers to the level of
understanding of disease mechanism and drug-target interactions across a wide searching space for the
combination of dosage and treatment time. Achieving depth requires a reliable AD model system that
comprehensively recapitulates AD pathogenesis in a human brain-like environment, and sophisticated
transcriptomic profiles, which can reveal molecular-level changes underlying disease-reversing phenotypes
across multiple treatment conditions. The width of a therapy search relies on the efficacy of predicting and
validating effects of candidate compounds from an enormous search space. Width can be achieved from novel
computational algorithms connecting –omics changes with phenotypic changes, thus guiding the search with
improved knowledge on mechanisms and avoiding exhaustive testing of every available drug.
Integrating the systems medicine and drug repositioning expertise of the Wong Lab at the Houston Methodist
Research Institute of Houston Methodist Hospital with the Alzheimer's biology expertise of the Kim and Tanzi
labs at Massachusetts General Hospital, we propose a SysteMatic Alzheimer's disease drug ReposiTioning
(SMART) framework based on bioinformatics-guided phenotype screening. Reformatting a novel three-
dimensional human neural stem cell culture model of AD (a.k.a. Alzheimer's in a dish) developed in the Kim
and Tanzi labs for high content screening, the Wong lab screened 2,640 known drugs and bioactive
compounds and obtained a panel of 38 primary hits that strongly inhibit β-amyloid-driven p-tau accumulation.
We hypothesize that iteratively running relatively small screens with our novel 3D cell model and applying
systematic artificial intelligence modeling to the transcriptomic profiles of the screening hits will allow us to: 1)
quickly obtain a panel of robust novel drug candidates for AD, and 2) gain an in-depth understanding of
disease mechanisms from those repositioned drug candidates, which will subsequently improve the success
rate of predicting novel hits.
Using the primary 38 hits as a starting point, the SMART computational modules will update the existing
NeuriteIQ software package to quantify the image data from high content screening; it will also incorporate
publicly available big data transcriptomic profiles to predict candidate compounds inducing similar pathway
changes as those original compounds, effectively expanding the search width to tens of thousands of
compounds while only requiring functional validation of less than 100 drug candidates. The validated
predictions will, in turn, add to the panel of known hits that will launch the next round of computational
predictions and experimental validations, efficiently generating candidates for novel AD therapies (Aim 1).
SMART's iterative prediction-validation scheme effectively connects more transcriptomic profiles to desirable
phenotypic changes. Thus, we will apply systematic image-omics modeling to uncover novel mechanisms
driving such phenotypes. For all the validated hits, dose-responses for the phenotype of pTau inhibition will be
obtained using the 3D culture model; while the dose-responses for individual genes and pathways will be
modeled through public and in-house generated transcriptomic profiles. We will use Partial Least Square
Regression models to identify gene modules with matching dose-response curves as the phenotypes, thus
allowing us to go beyond the confinement of canonical pathway maps and identify novel functional modules
specifically related to phenotypes of interest (Aim 2).
Selected compounds derived from the previous two aims will be evaluated in human neurons directly derived
from AD patients and in animal models (Aim 3).
Success of this work will lead to new AD therapeutic compounds ready for translation into clinical trials, as well
as a deeper understanding of the molecular mechanisms of AD pathophysiology. In addition, the SMART
framework for drug repositioning will be generalizable to other big data and disease platforms.

Public health relevance
Project Narrative (Public Health Relevance) Alzheimer's Disease (AD) currently afflicts 5.3 million people in the United States alone. Beyond symptomatic treatments, no clear therapeutic options are available. The proposed study provides a systematic drug repositioning strategy that uses a novel 3D human neural culture model (Alzheimer's-in-a-dish) integrated with a computational platform that leverages publicly available toxicology and pharmokinetic big data. Success of the study will greatly reduce the cost of AD drug development, identify potential new disease mechanism, and facilitate quicker translation from bench to bedside. .